Innovation in Medical Evidence Development and Surveillance(IMEDS)serves to advance the science and tools necessary to support post-market evidence generation on regulated products.

Opportunity Title: IMEDS-Methods Research Agenda Offering Agency: Food and Drug Administration CFDA Number: 93.103 CFDA Description: Food and Drug Administration_Research Opportunity Number: RFA-FD-15-010 PI Name: Susan Gruber Project Title: IMEDS-Methods Research Agenda Abstract: IMEDS-Methods is a program within the Reagan-Udall Foundation (RUF) that supports the FDA’s scientific mission of serving public health needs by initiating and facilitating research into the methods of safety evaluation in large databases. IMEDS-Methods aims to improve the tools for conducting post- marketing safety surveillance using automated healthcare data and to foster their adoption. In meeting this mission, IMEDS-Methods also adds to the general body of knowledge for using automated health data for broader post-market evidence generation on regulated products.1 The overarching goal of the IMEDS-Methods Program is to reduce uncertainty in the FDA’s ongoing evaluation of marketed medical products. Projects on the IMEDS-Methods 2015 Research Agenda are geared towards improving our ability to use electronic healthcare data to inform regulatory decision- making. IMEDS plans to fund projects in five core areas: (1) addressing bias in estimates from observational studies; (2) better understanding uses and limitations of the data; (3) applying lessons learned from earlier IMEDS projects to FDA surveillance activities; (4) expanding the surveillance question to continuous Risk/Benefit assessment; and (5) continuing to support qualified investigators in industry, government, and academic settings by providing access to de-identified electronic healthcare data and computing resources through the IMEDS Research Laboratory. Enhancements to the IMEDS Research Lab include developing novel tools and additional data sources to investigators in the research community. 1 Innovation in Medical Evidence Development and Surveillance (IMEDS) Charter. http://www.reaganudall.org/our-work/safety- and%20better-evidence/imeds-program/imeds-charter/ accessed September 30, 2013. First Draft Completed: April 2013 Proposed Revised Draft: August 2013; Section 3.1

Public health relevance
PROJECT NARRATIVE: IMEDS has an overarching goal of reducing uncertainties in the use of large health databases for evaluating marketed medical products. To this end, and in its status as part of the Regan-Udall Foundation for the FDA, IMEDS is attentive to the FDA’s specific expressed needs in this area. IMEDS sees its research mission as extending as well to the needs of the larger community of stakeholders in the arena of medical product safety. In addition to the FDA, the community includes academic clinical researchers, product manufacturers, and regulatory bodies outside of the US. For each of these, the pursuit of patient well-being is the fundamental justification for their work.